The Neuropathologic Landscape of Alzheimer's Disease in Hispanic Decedents

ABSTRACT Citizen science, public participation in the scientific process, leverages the unique properties of human cognition to distribute the analysis of massive data sets to the general public. Recently, the Human Computation Institute (HCI) used this approach to crowdsource the analysis of in-vivo two-photon excitation microscopy (2PEF) data, which has accelerated Cornell University’s Alzheimer’s disease (AD) research by a factor of five, elucidating molecular mechanisms that underlie capillary stalling in mouse models of AD. For this administrative supplement, we now propose to develop and validate a new online platform that crowdsources the histopathological analysis of whole slide images (WSI) of the human brain. This would support the rapid acquisition of high-volume datasets needed to train an automated classifier in support of our existing R01 studies investigating the neuropathological landscape of AD within Hispanic and non-Hispanic White decedents. Deriving research-grade classification labels from multi-source WSI entails data quality requirements that exceed today’s best automated methods. Thus, we intend to develop a crowd-powered analytic pipeline that reduces the histopathological analysis into a step-wise series of manageable online tasks that could be accomplished by non-expert members of the general public, as well as “wisdom of crowd” methods for aggregating many individual answers into a single expert-like answer. In service of these objectives, our specific aims are to develop the process, interfaces, and aggregation methods needed to support the crowd-powered analytic pipeline and evaluate its internal validity. We will employ a repeated cross-validation protocol to test the hypothesis that the crowd-based analysis will result in at least 95% sensitivity and 95% specificity for two major pathology categories (plaques and tangles) relative to gold standard data provided by expert annotators. If these validation studies are successful, an online platform incorporating this analytic pipeline will be used to execute the first ever de novo analysis of Alzheimer’s histopathology imagery by a crowd of volunteers (geared towards those of Hispanic heritage), be used to train a neural network model for automating the analysis, and will support the ongoing improvement of a reusable digital pathology workflow tool that is sensitive to an expanding repertoire of pathology targets.

Public health relevance
NARRATIVE This proposal will speed up Alzheimer’s research by automating pathology classifications through crowd-based generation of neural network training data. The attendant citizen-science platform will support ongoing improvement of an open digital pathology tool that is sensitive to an expanding repertoire of histopathology targets. The platform will engage Hispanic communities directly impacted by this research in its very execution, while providing a culturally responsive outreach and inclusion program for these communities to represent themselves in discussions with researchers.